Immunomodulation in AAV gene therapy

Abstract
Recombinant AAV vectors have emerged as promising gene delivery vehicles in the treatment of monogenic
disorders. With 6 different FDA approved AAV-based therapies, many additional disease targets requiring
systemic dosing continue advancing towards the clinic. However, immune responses arising from prior natural
AAV exposure or nascent exposure to recombinant AAV vectors dosed in human subjects poses a major
challenge. Evidence from multiple gene therapy clinical trials confirms that high vector doses can trigger cytokine
release leading to nausea, fever, and vomiting, and manifest in liver toxicity (elevated enzymes). In some
patients, complement activation following systemic AAV dosing has been shown to result in thrombotic
microangiopathy (TMA) and acute kidney injury (atypical hemolytic uremic syndrome-like), thrombocytopenia,
myocardial injury, and even death. Many of these adverse reactions can be attributed to AAV capsid-antibody
interactions highlighting a major (if not predominant) role for humoral immunity. Prophylactic measures or
symptom management have generally included plasmapheresis, administration of tapering, high doses of
glucocorticosteroids, hemodialysis, platelet transfusion, different drugs or monoclonal antibodies to block
complement/B cell activation or induce B cell depletion amongst others. More recently, preclinical testing of
agents such as Imlifidase or Vyvgart for promoting IgG clearance has been initiated. However, these current
management or mitigation strategies for these clinical sequalae are applied on a case-by-case basis with no
specific consensus immunomodulatory regimens (IMRs) in place. Thus, there is a clear and urgent need to better
understand, preclinically model and manage these complex sequalae (focus of the current proposal). To this
end, our lab recently engineered a novel immunomodulatory agent, IceMG – a recombinant, dual activity
protease that can selectively and efficiently cleave human and monkey IgG/IgM. Here, we propose to build on
our exciting findings and validate that IceMG is a potent blocker of complement activation as well as modulator
of B cell signaling pathways in human models in vitro and humanized mice as well as non-human primates in
vivo, thereby charting a path for first-in-human Phase I trials utilizing this IMR. Further, we will engineer and
characterize next generation immunomodulators (IceRx) for clinical translation. If successful, the current
proposal will enable development of new and improved IMR, essential for the success of AAV gene transfer
vectors in the clinic. The proposed strategies may also pave the path for clinical applications in autoimmune
disease and organ transplantation.

Public health relevance
Narrative The current proposal is focused on developing a novel immunomodulatory regimen for broad use with AAV gene therapy. We propose to engineer new immunomodulatory reagents that can address the problem of pre-existing immunity against AAV gene delivery vehicles that can result in reduced efficacy as well as safety concerns due to immunotoxicities such as triggering complement activation. Overall, the proposed studies are aimed at establishing a safe, transient and tolerable immunomodulatory regimen in preclinical models that ultimately enables AAV vector dosing in seropositive subjects with potential for broad impact in gene therapy applications and beyond.